Validation of Antimicrobial Resistance Data Analysis and Quality Control Procedures for Whole Genome Sequencing Using Commensal E. coli from Multiple Animal Species

1 Project Summary: Veterinary diagnostic laboratories currently lack universal standardized
2 methods and quality control for WGS data analysis with regard to assessing antimicrobial
3 resistance (AMR). As the FDA CVM is currently funding AMR monitoring and whole genome
4 sequencing (WGS) this is a significant gap. Additionally, AMR monitoring is lacking in minor
5 agricultural animal species and companion animals and should be included for holistic AMR
6 monitoring in veterinary medicine. This project addresses these gaps by developing data quality
7 criteria needed for AMR analysis using WGS, developing a bioinformatics pipeline with quality
8 assurance and quality control criteria tailored to veterinary diagnostic laboratory use and
9 providing AMR monitoring in minor agricultural animal species and companion animals. Not
10 only do resistant bacterial infections impact animal health and welfare, but they also have
11 significant potential for causing negative human health consequences through transmission of
12 resistant bacteria or resistance genes through food or animal contact. The use of common
13 classes of antimicrobials in humans and animals increases the likelihood that drug resistance
14 selected for in animal species could impact humans. Therefore, monitoring AMR in animals has
15 the potential to mitigate not only disease in animals but human infections as well. Recent
16 reductions in sequencing cost has provided an opportunity for veterinary diagnostic
17 laboratories to consider utilizing this technology for antimicrobial resistance assessment.
18 Escherichia coli, a microbe commonly harbored in multiple animal species will be used to
19 optimize and validate of existing bioinformatics platforms and bioinformatics quality
20 assurance/quality control procedures related to AMR. During the first year of funding the
21 laboratory will use reference strains of E. coli with known resistance phenotypes and genotypes
22 of interest including resistance to third generation cephalosporins, fluoroquinolones,
23 carbapenems, and aminoglycosides to optimize the sequence data quality assurance/quality
24 control and AMR bioinformatics analysis. In subsequent years, commensal E. coli will be
25 isolated from submissions to WADDL from multiple animal species for performance of
26 phenotypic AST and WGS for continuation of optimization and validation of the process, and
27 expansion of AMR monitoring in veterinary species. A summary of the data will be provided to
28 FDA CVM Vet-LIRN yearly and a standard operating procedure at the conclusion of the study.
29
30

Public health relevance
Project Narrative: Antimicrobial resistance monitoring is a critical function for veterinary diagnostic laboratories to aid in identification of new or emerging resistance, to identify potential resistance reservoirs, and assess efficacy of interventions to reduce resistance development. Not only do resistant bacterial infections impact animal health and welfare, but they also have significant potential for causing negative human health consequences through transmission of resistant bacteria or resistance genes through food or animal contact. Expansion of validated whole genome sequence data analysis and data quality assurance/ quality control for bacterial resistance detection increases the ability of FDA Center for Veterinary Medicine to accurately detect resistance and provide more accurate monitoring of antimicrobial resistance in veterinary species.